New Epidemiologic Methods for Reducing Measurement Error and Misclassification Bias in Cancer Epidemiology

Project Summary/Abstract
Uncertainty in exposure and outcome measurements poses substantial challenges to the identification and
quantification of the causes of cancer. For example, although difficult to measure well, physical activity patterns
form the basis of many etiologic hypotheses concerning cancer risk. Cancer cases identified in electronic
health records (EHR) and other administrative ‘big data’ sources, such as Medicare claims data, are also
subject to misclassification. This exposure and outcome uncertainty leads to considerable bias in estimated
health effects, masking our ability to detect true associations, which are likely underestimated if detected at all.
It is the role of measurement error and misclassification correction methods to validly and efficiently estimate
the relationship between exposures and cancer outcomes. To accomplish this, a validation study is required for
estimating key features of the error process. Although much has been accomplished in this domain over the
years, the current aims address unsolved problems of high scientific significance that would otherwise remain
unanswered without this additional work. We will drill down into the multi-faceted themes that arise in cancer
research, tackling several seminal new directions of critical importance for the translation of the results of
population-based research to practice and policy. These methods will include estimation of the effects of
within-individual change in lifestyle behaviors on cancer risk corrected for measurement error in the change
variables, utilizing complex, currently under-accessed validation studies of diet and physical activity comprised
of repeated paper and online questionnaire self-reports and repeated concentration and recovery biomarkers
to obtain relative risk estimates unbiased by general measurement error structures which may include
correlated and biased errors, and estimating effects of exposures, including medications, other clinical
treatments, and health behaviors, on cancer incidence in EHR data. The new methods will be applied to
studies of the impact of within-participant change in alcohol intake on breast cancer incidence in the American
Cancer Society’s CPS-II cohort and in Harvard’s Nurses’ Health Study, and to a study disentangling the
impacts of diabetes and diabetes medications on colorectal cancer risk in Yale New Haven’s Epic EHRs.
Dissemination is a central feature of this research. User-friendly publicly available software will accompany all
new methods to be developed. The new methods will be disseminated through short courses and lectures at
national and international epidemiologic and statistical conferences, and through the development of a massive
online open course (MOOC). We have assembled an outstanding team of experts in measurement error
methods and statistical theory, along with an exceptional team of cancer epidemiologists with much prior
collaborative experience with the methods team, to guide the developments and their applications to the
scientific problems at hand. With the talented junior faculty and trainees to be recruited for this project, we will
solve the challenging problems that have been identified.

Public health relevance
Project Narrative Uncertainty in exposure measurements is a major source of bias in epidemiologic research aimed at elucidating causal relationships between risk factors, such as physical activity, in relation to cancer incidence and mortality, and misclassification of cancer incidence induces additional bias in studies based upon electronic health record data and other administrative ‘big data’ sources of information, such as Medicare claims data. We will develop novel epidemiological methods for valid and efficient estimation of nutritional and lifestyle effects on cancer risk, from estimation of relative risks related to within-individual change in lifestyle exposures to resolving challenges arising in the study of physical activity, diet, co-morbidities and health behaviors in relation to cancer risk due to measurement uncertainty, and apply these new methods to studies arising in the American Cancer Society’s Cancer Prevention Study II, Harvard’s Nurses' Health Study, the National Cancer Institute’s IDATA, Harvard’s Women’s and Men’s Lifestyle Validation Studies, and Yale New Haven’s Epic EHR data. With a major emphasis on methods dissemination, publicly available user-friendly software will accompany all new methods, a massive online open course (MOOC) will be developed, and short courses will be offered at national and international epidemiology and statistics conferences.